Development of Second Generation BLVRB Inhibitors for Treating Chemotherapy Induced Thrombocytopenia

PROJECT SUMMARY
Chemotherapy-induced thrombocytopenia (CIT) is one of the main dose-limiting toxicities of myelosuppressive
chemotherapy. Indeed, it is estimated that nearly 50% of chemotherapy patients with hematologic malignancies
and 33% with solid tumors develop CIT, with the likelihood of developing CIT being somewhat linked to the
treatment regimen and/or patient outcomes. Because proper platelet counts are essential for preventing bleeding
disorders, which may be fatal, physicians/healthcare providers must take measures to prevent/control CIT.
Currently, there is no FDA-approved therapeutic marketed for treating CIT. Previously, a redox defective mutation
in the gene BLVRB, which encodes biliverdin IXβ reductase, was identified in a cohort of patients with
thrombocytosis. Blood Cell Technologies, LLC has developed a first-generation BLVRB inhibitor that produced a
statistically significant increase in platelet numbers in mice with CIT, providing the first evidence for target
validation that phenocopies BLVRB-null mice. In this Fast-Track SBIR, we will develop second-generation
compounds, aiming to identify a lead-optimized (LO) small molecule inhibitor that will enhance the therapeutic
potential of our drug discovery program. This will be accomplished by 1) using in silico modeling to optimize the
potency and drug-like properties of the lead first-generation compound, 2) determining the therapeutic range of
the LO compound in a mouse model of CIT, 3) determining metabolites of the LO compound, 4) establishing the
LO compound’s pharmacokinetic profile, 5) conducting safety studies to determine its therapeutic index, and 6)
comparing its efficacy to thrombopoietin (TPO) and FDA-approved TPO receptor agonist (RA) in a mouse model
of CIT. The completion of the proposed work will extend to IND-enabling GLP toxicology studies and scale-up
production of the compound under current Good Manufacturing Practices (cGMP) to generate clinical trial
material to enable first-in-human clinical trials (beyond the scope of this proposal). Funding the development of
a potent, safe, and effective BLVRB inhibitor will play a key role in improving outcomes in patients who rely on
chemotherapy.

Public health relevance
PROJECT NARRATIVE Chemotherapy-induced thrombocytopenia (CIT) is a dose-limiting toxicity of myelosuppressive chemotherapy; however, there are no FDA-approved therapies for marketed treating CIT. This proposal aims to develop second- generation inhibitors of a novel target involved in thrombopoiesis. The compounds developed under this proposal will fill this gap and meet the critical need for a CIT treatment that will improve patient outcomes/survival.